Neurofeedback from the supplementary motor area for Tourette Syndrome

Abstract
The proposed project is a clinical trial to confirm the efficacy of a real-time fMRI neurofeedback intervention
that involves training adolescents with Tourette Syndrome to control a region of their supplementary motor area
(SMA) believed to be involved in tic generation. The intervention involves providing feedback on SMA activity
to participants while they practice regulating the region. They are cued to up-regulate and to down-regulate the
area at different times and encouraged to try mental strategies for both up-regulating and down-regulating that
have the potential to improve their symptoms. For up-regulation, this includes engaging in mental imagery of
complex motor activities, or doing mentally demanding cognitive tasks, in order to co-opt the relevant neural
circuitry for tasks other than tic generation. For down-regulation, this includes imagining relaxing scenarios that
tend to be associated with reduced stress levels and an associated reduction in tic severity. This intervention
was previously compared with a yoked sham control intervention in a small crossover design study that
yielded very promising results: large clinical effects were observed and the groups showed differences in their
ability to regulate the SMA during neurofeedback. Here we attempt to confirm that preliminary finding of
efficacy in a larger, purely randomized design that includes follow-up of participants, and critically, employs a
different form of control condition. In the proposed study, the control group will be trained via neurofeedback to
control a region of their visual association cortex that is believed to be unrelated to their symptoms. This
control region will be defined for each control subject in a manner that ensures it is not functionally connected
to their SMA. By using this new form of control condition, this study ensures that the intervention has been
tested against two of the most rigorous forms of control conditions used in clinical applications of real-time
fMRI neurofeedback (yoked sham and training on a control region). Given that the different types of control
conditions rule out different kinds of confounds, this is the most rigorous approach to testing this intervention: if
results are promising, they cannot be dismissed as an artifact of the kind of control condition used. In short,
with the proposed clinical trial, we aim to confirm the clinical efficacy of this new intervention, and to verify that
it is acting via the hypothesized mechanism of action (enhancement of control over the SMA via
neurofeedback). In addition, effects of the intervention on resting state functional connectivity patterns will be
examined to better inform our understanding of the network changes induced by the training.

Public health relevance
Narrative The proposed project aims to test a new neurofeedback intervention for adolescents with Tourette Syndrome that trains them to control activity in a region of their brain believed to be involved in tic generation. The clinical efficacy of the intervention will be evaluated. We will also monitor how the intervention affects brain patterns to confirm that it is working in the expected manner and to explore its effects on brain networks.